LDlink webtool for examining patterns of linkage disequilibrium in diverse popul

Exploring linkage disequilibrium (LD) across ancestral populations is a powerful approach for investigating population-specific genetic structure as well as functionally mapping regions of disease susceptibility. LDlink is a suite of web-based applications designed to easily and efficiently interrogate linkage disequilibrium in population groups. LDlink consists of several modules for interactively exploring linkage disequilibrium including LDassoc, LDexpress, LDhap, LDmatrix, LDpair, LDpop, LDproxy, LDtrait, SNPchip and SNPclip. Modules are designed with an emphasis on ease of use, query flexibility, and interactive visualization of results. Haplotype tables and interactive plots generated by LDlink are tailored for investigators interested in mapping common and uncommon disease susceptibility loci with a focus on linking correlated alleles and highlighting potentially functional variants.